BLRD Research Career Scientist Award Application

Dr. Paula C. Bickford is currently a Senior Research Career Scientist at the James A. Haley VA
Hospital in Tampa, FL. She continues to be a productive and collaborative VA scientist. She was
awarded the 2023 William S. Middleton Award reflecting her significant achievements as a VA scientist.
Her research focus is in the area of aging and neurodegenerative disease, specifically with a focus on
the innate immune system and how aging interacts with the innate immune system and how this then
impacts normal cognitive aging and the progression of many neurogedenerative diseases. It is now
well established that aging is the primary risk factor for a number of diseases that cross multiple
disciplines. The impact of this on research of neurodegenerative disease is that aging must be
considered as a co-morbidity factor in our models of disease, and in our approach to understanding
therapeutic treatments. It is the goal of Dr. Bickford’s funded research programs to understand these
complex biological processes in order to design interventions such that either existing or new
therapeutics against neurodegenerative diseases will be more effective. Her recent data suggests that
interventions that work in young animal models of disease are not as effective in aging models. Her
previous work examining this question directly with proteomics of young versus aged microglia and has
shown that several pathways involving nutrient sensing and energy metabolism within microglia are
altered and may underlie the change in pro-inflammatory phenotype that is observed with aging and
thus targeting the underlying mechanistic changes with age, rather than directly reducing pro-
inflammatory cytokines, may have broader impacts on increasing resiliency of the brain
microenvironment, and thus a broad impact on therapeutics of neurodegenerative disease. The focus
of a current VA merit on TBI is aimed at addressing this issue directly and recent unpublished work
suggests they can overcome this issue using a stem cell derived exosome approach, as it has many
potent actions in the aged brain. TBI is a major health risk in our VA population leading to many long
term sequelae. Furthermore, aging increases the risk of hospitalization, death and long term cognitive
deficits following brain injuries. Aging and TBI interactions are associated with an increase in
neuroinflammation, motor and cognitive dysfunction. Age at the time of injury is a well-known Indicator
of clinical outcomes, and older people are vulnerable to having more complicated neurological deficits
and impaired functional recovery after TBI. Research showed the aged brain is less resilient and
responsive to therapeutic intervention due to elevated inflammation that is characteristic of increased
aged. They have identified a powerful therapeutic approach for TBI that is effective when administered
intranasally up to days (and perhaps longer) following injury that reduces secondary inflammation and
thus long-term deficits following TBI. They are exploring the efficacy in aged animal models. They
have isolated microglia and astrocytes from young and aged brains for proteomics. They are using
spatial transcriptomics profiling to examine in details molecular changes near and far from the injury.
They are also exploring the role of T cells in PD models using scRNAseq.

Public health relevance
Dr. Bickford is a recognized leader in research as she has received numerous awards including being the 2023 William S. Middleton Awardee, Fellow of the American Association for the Advancement of Science. Her work is in the area of aging and neurodegenerative diseases. Millions of Veteran’s over the age of 65 are seeking care in our VA healthcare system, and aging is a critical, yet often overlooked risk factor for many diseases. Dr. Bickford’s work promises to unlock new and improved interventions in memory loss in aging as well as in Parkinson’s disease.